Using base editing to investigate CFTR polymorphisms in lung diseases

PROJECT SUMMARY
Lung diseases are among the leading causes of death worldwide. Genetic mutations underlie many lung
diseases. For instance, mutations in the cystic fibrosis transmembrane conductance regulator (CFTR) gene can
directly cause cystic fibrosis (CF) or increase the risk of other non-CF lung diseases, like chronic obstructive
pulmonary disease and asthma. To date, over 2,000 mutations have been identified in the CFTR gene, classified
as CF-causing or non-CF-causing polymorphisms. Correcting CF-causing mutations and exploring the function
of non-CF-causing polymorphisms could help treat a wide range of lung diseases.
CRISPR-associated base editing mediates the irreversible conversion of A>G (Adenine Base Editor, ABE) or
C>T (Cytidine Base Editor, CBE). The goal of this proposal is to use base editing to correct CF-causing CFTR
mutations in CF primary cells and mouse models, and to investigate whether non-CF-causing polymorphisms
affect CFTR activity and lung cell function. Preliminary data show that ABE can correct a CF-causing nonsense
mutation (W1282X) to restore CFTR expression and function in immortalized human lung epithelial cells. In the
K99 phase, ABE will be delivered to a clinically-relevant cell model, CF patient-derived primary bronchial
epithelial cell line, to correct W1282X, and rigorous off-target analysis will be performed to study the efficiency
and specificity of ABE (Aim 1). Moreover, an in vivo delivery method targeting lung airways will be developed by
packaging an intein-split ABE system into AAV5 (Aim 2). The delivery efficiency will be tested in wild type
C57BL/6 mice. GFP-CFTR reporter cell lines will also be established using CRISPR-mediated homology directed
repair method to integrate a GFP sequence to CFTR genomic locus (Aim 3). Research in the mentored phase
will be performed under the guidance of an esteemed mentor committee, whose expertise range from CRISPR
engineering and application to pulmonary biology. By the R00 phase, the PI will be ready to establish an
independent laboratory focused on using base editing techniques to study point mutations in lung disease.
During the R00 phase, AAV5-ABE will be delivered to W1282X CF mice to determine its potential as a novel
gene therapy method to correct an “untreatable” CFTR mutation in CF (Aim 2). Furthermore, non-CF-causing
mutations will be introduced by CBE in lung airway epithelial cells to understand how they affect CFTR
expression, localization, and function, and how they respond to known CFTR modulator drugs – e.g. ivacaftor
(Aim 3). These studies will reveal if and how non-CF-causing mutations contribute to lung disease, and suggest
potential treatment approaches for lung diseases associated with non-CF-causing mutations. Collectively, the
proposed studies will shed light on diagnosis and treatment of lung diseases that are associated with CFTR
polymorphisms. This project will foster the PI’s continued scientific and professional training and facilitate her
transition to independence.

Public health relevance
PROJECT NARRATIVE Genetic mutations underlie cystic fibrosis (CF) and other respiratory lung diseases that are global public health burdens. This study seeks to use a gene editing technique to correct a mutation causing CF and to investigate the role of understudied CFTR mutations in the development and progression of lung disease. Findings from this work will inform the diagnosis and treatment of genetic lung diseases.